The Effects of Declining Nursing Home Capacity on Post-Acute and Long-Term Care Access and Health Outcomes among Older Adults and their Caregivers

Nursing homes are cornerstones of the US post-acute and long-term care systems, serving over 4 million older
adults, more than half of whom have Alzheimer’s disease or Alzheimer’s related dementias (AD/ADRD).
Despite their importance, older adults’ access to these facilities may be approaching a state of crisis. The
Covid-19 pandemic disrupted the nursing home industry and resulted in historic and persistent staffing
shortages, raising concerns that many facilities may be forced to reduce capacity or close entirely. Our
preliminary data analyses indicate these concerns are well-founded. We estimate that functional nursing home
capacity has declined by nearly 10% following the pandemic, with nearly 40% of US counties experiencing a
decline of 15% or more. The implications of these capacity declines are not well understood but have the
potential to be catastrophic. For example, inadequate nursing home capacity may result in disrupted care
transitions and slowed recovery following hospitalization, patients languishing in hospitals while awaiting a
nursing home bed, increased risk of injuries from inadequate personal care, and increased strain on family
caregivers who often fill in the gaps when care is provided at home. Policymakers have several tools at their
disposal to stabilize or expand the nursing home market, including increasing payment rates, removing barriers
to new market entrants, and increasing financial incentives to provide care in shortage areas and/or to patients
with reduced access. However, there is a glaring evidence gap regarding the need to intervene, the types of
interventions needed, and where these interventions should be targeted. Our proposal will close this
knowledge gap with rigorous quantitative analyses that will determine the effects of reduced nursing home
capacity on three populations. In Aim 1, we will use Centers for Medicare and Medicaid Services (CMS)
administrative data and hospital-level variation in the extent of post-pandemic nursing home capacity declines
to estimate effects on the care transitions and recovery of hospitalized patients, with and without AD/ADRD,
with intensive post-acute care needs. In Aim 2, we will use similar data and county-level variation in capacity
declines to estimate effects on care access and injury risk for community-dwelling older adults with increasing
long-term care needs, as signified by a new AD/ADRD diagnosis. Aim 3 will estimate spillover effects on
spousal caregivers of older adults with post-acute or long-term care needs. It will use household-level survey
data linked with CMS data to identify couples and track spousal care delivery and health outcomes following a
partner’s hospitalization or diagnosis of a chronic condition, including AD/ADRD. Geographic information will
be used to identify exposure to post-pandemic nursing home capacity loss. Results from this proposal will
provide a comprehensive portrait of current US nursing home capacity and the ability of this market to meet the
institutional care needs of an aging population. Results will also support policymakers’ efforts to ensure
equitable access to nursing home care, regardless of geography or patient type.

Public health relevance
Project Narrative The number of available nursing home beds has decreased dramatically since 2019, raising concerns that many older adults, especially those with Alzheimer’s disease or Alzheimer’s related dementias (AD/ADRD), may not be able to access needed post-acute and long-term care. This research will provide rigorous empirical evidence on how these declines impact older adults’ care access, health outcomes, and spousal caregiver strain. Results will directly inform decision making related to the current state of the US nursing home market and whether intervention is needed to ensure it can meet the care needs of a rapidly aging population.